ITCA NARCH 12 Admin Core

NARCH (AIRCH) XII Administrative Core Abstract
The Administrative Core is critical to the success of the Center. It provides administrative, fiscal and
management oversight of all components and projects and guidance in evaluation and planning. Process is
key to the success of the Center and the Administrative Core provides the resources to keep all elements of
the Center functioning and moving forward and serves as a catalyst to engage all the partners in regular and
culturally respectful communication and relationship building.
Since its establishment in 1975 as a non-profit organization, the Inter Tribal Council of Arizona, Inc. (ITCA) has
advocated for self-determination for its Member Tribes through public policy development, research, and
education. The membership of ITCA is comprised of leaders from 21 federally recognized tribes in Arizona.
ITCA operates more than 30 projects and employs a staff of 70 to provide technical assistance and training to
tribal governments in program planning and development, research and data collection, resource development,
education, health, management and evaluation. Strengthening tribal governance is at the core mission of
ITCA including taking action on matters that affect Member Tribes individually or collectively and promoting
tribal sovereignty.
The University of Arizona and the Inter Tribal Council of Arizona boasts a successful 20-year partnership
through the NARCH program in the American Indian Research Center for Health (AIRCH) along with
establishing new relationships with Arizona State University. Our application for the Native American Research
Center for Health XII (NARCH XII) focuses on improving health disparities in our Tribes by strengthening tribal
governance through research. We propose six projects:
1. A capacity building project to assist Tribes with building research capacity to support ITCA Member
Tribes in implementation and evaluate their own community-based research projects through a
competitive process to receive technical assistance and mentorship from a team of American Indian
researchers at The University of Arizona;
2. A student career enhancement program to establish the Rising Stars Program to create a health,
science, technology, engineering, math field (HSTEAM) outreach program for American Indian/Alaska
Native (AI/AN) students and develop a HSTEAM Ambassador program with AI/AN students;
3. A faculty/researcher project to apply an innovative Indigenous ethics and data governance framework
grounded in Indigenous Peoples’ rights to equip early career researchers in Arizona with knowledge,
tools, and perspectives to create research relationships with tribal nations and Indigenous communities
that advance and benefit Indigenous Peoples rights and interests with collaborative partners;
4. A pilot project to establish vector-borne disease research committees in each tribal community by
examining community-level risk perception, conduct evaluative surveillance of arthropod vectors and
establish ongoing independent, needs-based, vector surveillance capabilities within tribal communities
is ideal;
5. A research project proposing on using data from emergency departments and hospitals throughout the
United States, to compare psychiatric diagnoses assigned to AI/ANs with substance use disorders to
assist policy makers and public health experts to actively address concerns if indicated and;
6. A pilot project to evaluate the isotopic abundance of wastewater extracts via high-resolution mass
spectrometry to determine the drug source (pharmaceutical, manufactured, natural, etc.) comparing
results to archived standards and between Tribes and engage Tribes in Community-Based
Participatory Research to build capacity and collaborations, and train stakeholders to use the data most
efficiently to benefit the Tribal community.

Public health relevance
NARCH XII Administrative Core Narrative The Inter Tribal Council of Arizona, Inc. (ITCA), is a tribally controlled non-profit organization established in 1975. ITCA has the goal of promoting American Indian self-reliance through public policy development, and to provide Member Tribes with the means for action on matters that affect them collectively and individually. The Member Tribes of ITCA are 21 federally-recognized Tribes located in the State of Arizona. The highest elected official of each Member Tribe serves on the council. These leaders have a comprehensive view of the conditions and needs of the tribal communities they represent. ITCA provides an independent capacity to obtain, analyze, and disseminate information vital to tribal community self-development. To build upon the ethical approach of research among the tribal communities, and continue a long- standing relationship with The University of Arizona and Arizona State University in creating a space for developing AI/AN science focused students and faculty. ITCA proposes to provide the infrastructure for the Native American Research Centers for Health (NARCH) projects as the Administrative Core ensuring all rules and regulations of the award are delivered, along with efficient communication providing accountability of NARCH oversight.